Heterogeneous genetics effects and mediation in Alzheimer's disease

Project Summary
Down syndrome (DS) is the most common genetic intellectual and developmental disability and has historically
been associated with poor life expectancy. However, improvements in medical care have increased the lifespan
of individuals with DS to above 60 years. Individuals with DS have an increased risk of Alzheimer’s disease
(AD), largely due to triplication of the amyloid precursor protein (APP) gene on chromosome 21, which results in
amyloid-beta (Aβ) plaque deposition. Individuals with DS also frequently have co-occurring medical conditions
such as sleep apnea, hypothyroidism, and cardiovascular disease, which contribute to pathology that may be
directly or indirectly implicated in AD pathology and cognitive decline. Thanks to increasingly comprehensive
datasets that include clinical, biospecimen, and imaging data on individuals with DS, it has become feasible
and critical to understand the direct and indirect associations between these co-occurring conditions and AD
in DS. By utilizing data from what is currently the largest AD biomarker study in DS, Alzheimer’s Biomarker
Consortium for Down syndrome (ABC-DS), we propose to develop innovative statistical approaches combining
Bayesian inference and flexible machine learning to efficiently explore individual-level heterogeneity in DS. First,
we propose a method based on Bayesian additive regression trees (BART) to capture individual-level differences
in the effect of APOE genotype on Aβ levels in the presence of missing covariates. Second, we will develop
a BART-based heterogeneous causal mediation model to estimate the indirect effects of DS/trisomy 21 on Aβ
mediated by cardiovascular disease and moderated by demographics and patient/family medical history. By
successfully completing the project, we expect to elucidate the role of cardiovascular disease for AD in DS with
the two novel statistical methods proposed in this project.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is highly prevalent in people with Down syndrome (DS). We propose to identify the role of cardiovascular disease and genetic factors for AD biomarker amyloid beta in the DS population. The findings will deepen our understanding of the etiological mechanisms of AD in DS.